Opportunistic Screening for ASCVD using a Multimodal Deep Learning Risk Prediction Model

PROJECT SUMMARY
Atherosclerotic cardiovascular disease (ASCVD), such as stroke and heart attack, is the leading cause of
morbidity and mortality globally, responsible for approximately 19 million deaths annually. Risk assessment is
the cornerstone for primary prevention of ASCVD. Pooled Cohort Equations (PCE) are currently used to guide
risk assessment and tailor preventive therapies. However, these and other risk prediction tools remain imperfect
and have significant limitations including being static and based on a small number of simple clinical variables
as well as having poor performance across diverse populations. Moreover, they do not incorporate imaging that
may contain known prognostic biomarkers of future risk. For example, CT scans of the chest contain coronary
artery calcium (CAC), thoracic aortic calcium (TAC), intrathoracic (IF), and body composition (BC) metrics.
However, these biomarkers are not routinely reported in clinical practice nor accounted for in PCE. Finally, PCE
has also been shown to misestimate risk in certain ethnicities despite identical risk profiles. We will develop a
comprehensive graph-based fusion model, “ADMIRE” (AscvD Multimodal rIsk pREdiction), that incorporates
imaging and non-imaging data across two diverse sites – Mayo Clinic and Emory Health System. Our
multidisciplinary team of radiologists, informaticists, AI scientists, and preventive cardiologists will leverage our
prior experience with developing fusion models for risk prevention. We will validate our previously developed
biomarker segmentation models on a diverse cohort as well as develop a comprehensive semantic segmentation
model that incorporates multiple known prognostic biomarkers (AIM 1). We will then apply debiasing techniques
to develop ‘fair’ models and evaluate performance on cohorts stratified by demographic (e.g., race, gender,
social determinants of health surrogates) and imaging (e.g., scanner type) factors (AIM 2). Finally, we will use a
novel graph-based technique to create a fusion model to show performance against PCE and on stratified
cohorts based on demographics (AIM 3). We designed this study such that dependencies between experiments
are reduced. We hypothesize that multimodal fusion models incorporating imaging and non-imaging biomarkers
will have a greater prognostic performance than PCE. We further hypothesize that algorithmic model debiasing
can allow more effective at-risk prediction for minority patients in which PCE is known not to perform well. Our
proposal could potentially allow greater opportunistic screening of patients for primary prevention of ASCVD and
overcome limitations of current risk assessment tools such as PCE.

Public health relevance
PROJECT NARRATIVE Routine chest CT examinations contain prognostic information that is often underutilized for its value in primary prevention of atherosclerotic cardiovascular disease (ASCVD), leaving missed opportunities for incidental screening to predict future cardiovascular events, such as heart attack and stroke. Current risk assessment tools, such as Pooled Cohort Equations (PCE), are poor predictors of ASCVD due to data limitations, most notably the static nature of the data and lack of model complexity, resulting in misestimation in minority groups. A graph- based multimodal fusion model that integrates imaging and electronic medical record data is essential to addressing the data limitations of outdated tools and creating more sophisticated technology that supports opportunistic screening of a larger, more diverse population of patients as well as earlier prevention strategies and therapeutics.